STUDY OF THE POTENTIAL USE OF CATALYTIC ANTIBODIES AGAINST AIDS

Three peptidic transition-state analogs have been proposed from highly-conserved polypeptide segments of the HIV-1 envelope glycoprotein and two of these analogs have been synthesized and used as immunogens for the production of murine monoclonal antibodies. Several hundred hybridomas have been shown to bind to the transition-state analog used for immunization and several of these show differential binding to the transition-state analog vs the original-sequence peptide.